FEND for TB

ABSTRACT
In response to RFA-AI-19-030, Feasibility of Novel Diagnostics for TB in Endemic Countries
(FEND-TB) the leadership team has brought together a consortium of experienced investigators
and clinical sites and developed a research plan to address critical unmet TB diagnostic needs.
This program benefits from experience gained during the successful 7-year tenure of the NIH
DMID-funded TB-Clinical Diagnostics Research Consortium (TB-CDRC), with overlap in
leadership, investigators and sites. This program has been adapted in several ways to further
enhance capacity to meet the current challenges in the field -- the successful collaboration with
the Foundation for Innovative New Diagnostics (FIND) has been strengthened to now a full
partnership that will facilitate access to cutting edge technologies and alignment of FEND-TB work
with global stakeholder priorities; clinical study sites in India and Peru have been added to
accelerate recruitment and augment capacity to enroll patients with co-morbidities and drug-
resistance; inclusion of a mature analytic laboratory and revised technology evaluation strategy
that together allow for rational, nimble, step-wise evaluation of early-stage diagnostics; and
inclusion of mathematical modeling capacity to inform optimal diagnostic strategies in TB endemic
settings. This proposal will test two main hypotheses: A. Novel early stage TB diagnostics, that
target bacterial and/or host targets and will be ready for evaluation in the next five years, will have
performance characteristics suitable for point of care (POC)/near-care use for TB detection,
triage, or drug susceptibility testing. B. Rapid non-sputum diagnostics will provide ancillary
support as components of algorithms for the diagnosis of childhood TB as well as paucibacillary
pulmonary TB and extrapulmonary TB in adults. Specific Aims are: 1. To evaluate the diagnostic
accuracy of early stage diagnostic tests for tuberculosis. 2. To identify new early stage
diagnostics for evaluation, and to develop and implement for each a stepwise evaluation plan. 3.
To use economic analysis and transmission modelling to design optimal diagnostic algorithms.

Public health relevance
PROJECT NARRATIVE Tuberculosis is a leading cause of death due to an infectious disease. Most cases occur in low and middle income countries where access to diagnostics such as culture may be limited to a few reference centers. FEND for TB will identify and assess inexpensive tests that are available at the point of care where the patients first are evaluated; once validated, these tests will enable more rapid identification and treatment of TB.